Core--Flow Cytometry

All of the Projects of this Program are very healthily dependent on analysis by6 flow cytometry. Three Becton-Dickenson instruments for this are available to the group. Funds are requested to support the maintenance and necessary repairs for these instruments to ensure that they are available at all times to the investigators.